TAS::75 0862::TAS - NTP TOXICOLOGIC POTENTIAL OF SELECTED TEST AGENTS

Studies to Evaluate Cardiotoxic Disease Process in Three Strains of Mice Exposed to bis(2-Chloroethoxy)methane or a Mixture of Ephedrine and Caffeine